Project 3

ABSTRACT: PROJECT 3 (P3)
Background: Electronic (e)-cigarettes are the most commonly used tobacco product in adolescents and young
adults. E-cigarette use is associated with subsequent cigarette initiation in this population. E-cigarette product
diversity (i.e., product characteristics and associated marketing strategies) could be a target for FDA product
standards and marketing restrictions to reduce the adverse impact of e-cigarettes in young people. Yet, there
has been little evidence on this topic. P3 will test hypothesized e-cigarette product characteristics and marketing
strategies that may attract never-smokers and put them at risk for tobacco product use but do not affect the
likelihood that young smokers will adopt and switch to e-cigarettes. Such data will inform regulatory policies that
meet FDA’s mission to ‘protect the population as a whole.’ Example hypothesized product features that may
disproportionately attract never smokers (vs. smokers) include sweet flavors (vs. tobacco or other flavors), de-
vices and e-liquid compositions used to generate large aerosol clouds for “vape tricks’ (vs. devices that look and
feel like cigarettes), and youth-oriented marketing strategies for e-liquid naming, such as “Kustard Killer,” and
packaging with (vs. without) cartoon images. Method: P3 will test these hypotheses in a large Center-wide USC-
TCORS cohort (N=6400) overseen by the Population Core. Rich longitudinally collected data, including up to 8
years of cumulative follow-up will span critical developmental windows from 14-24 years of age, during which
lifelong tobacco use patterns have historically been established. Aim 1. To investigate the association of: 1a) e-
cigarette product diversity with appeal and interest in e-cigarettes, using an innovative within-subject experi-
mental design including exposure to still images of products and marketing, and GIFs of vape clouds embedded
in computerized survey interface (developed with assistance from the Administrative Core and other projects),
1b) e-cigarette interest with subsequent e-cigarette initiation, and 1c) product marketing exposure via various
channels with e-cigarette initiation. Aim 2. To evaluate the association of 2a) e-cigarette initiation with tobacco
product use outcomes (i.e., e-cigarette and cigarette progression to regular use, dependence, and cessation),
and 2b) e-cigarette product characteristics and marketing exposures (via several channels) with tobacco prod-
uct use outcomes. Aim 3. To evaluate whether associations of product characteristics and marketing with out-
comes observed in Aims 1 and 2 differ between baseline never-smokers and smokers. Integration with “Inter-
sections of Products with Populations” theme: P3 will study a variety of domains of e-cigarette product di-
versity that overlap with and complement domains studied by the other USC-TCORS projects. P3 uniquely
addresses population diversity in the Center by comparing current smokers while they are still young (age <24)
with never-smokers. P3 will also examine differential associations by sex, race/ethnicity, sexual orientation, and
socioeconomic status. FDA Scientific domains addressed: Addiction, Behavior, and Marketing.